Use Explainable AI to Improve the Trust of and Detect the Bias of AI Models

Project Summary/Abstract
AD/ADRD is a growing national public health crisis as the number of Americans ≥65 years
is projected to double by 2050. Our parent grant was designed to measure cardiorespiratory
fitness (CRF) as a biomarker of physical activity in the most extensive epidemiological study in
nearly 1 million Veterans using VA’s world-class electronic health record and advanced artificial
intelligence technologies. The parent grant aims are (1) to determine the relationship between
CRF and incident AD/ADRD, taking into consideration a non-linear relationship and potential
interactions of CRF with other risk factors and (2) to define incremental CRF levels that are linked
to progressively lower risk of AD/ADRD, overall, and in subgroups by age, sex, and race. Our Aim
3 is to develop and validate a deep learning-based risk prediction model to determine the optimal
CRF level for individuals to achieve the lowest risk of AD/ADRD. Deep learning is a key Artificial
intelligence (AI) technique. AI has demonstrated great strides in the past decade. However, AI
models are often viewed as “black box” as they are difficult to explain. Understanding what an AI
model does is a prerequisite to the ethical use of AI, because stakeholders can’t trust a model or
detect the potentially intended and unintended biases associated with the development or
utilization of the model without understanding it. We believe that explainable AI is a powerful tool
to address the bioethics issues of trust and bias. The purpose of explainable AI is to make it
possible for human users to understand and trust the decisions or recommendations offered by
the AI model, and to debug and refine it. Specifically, this supplement will test the effect of AI
model explanation on trust and bias detection in a simulated environment by recruiting a set of
stakeholders and using a scenario-based approach. The potential broad impact of the proposed
work is that it will advance the ethical development and use of AI/ML in biomedical and behavioral
sciences using explainable AI methods.

Public health relevance
Narrative Without understanding what an AI model does, it is impossible for the stakeholders to trust the model or to detect the potentially intended and unintended biases associated with the development or utilization of the model. Trust and bias are two important ethical issues we propose to address in this supplement through the utilization of explainable AI methods. In this supplement, we will test the effect of AI model explanation on trust and bias detection in a simulated environment, building on the AI model and explanation method development that are part of the parent award on AD/ADRD and fitness.